Pain in the Elderly: Role of Hyperalgesic Priming

Abstract
Management of pain is a significant problem in the elderly, with the burden of chronic pain
heavily tilted toward older adults. The high incidence of pain in the elderly has been suggested to
be related to an increase in stress and underlying painful conditions throughout the life span (e.g.,
inflammation, surgery, disease, chemotherapy, and other stressful life events), which led the PI
to her central hypothesis that nociceptor neuroplasticity in the elderly contributes to this increase
in chronic pain. Hyperalgesic priming (priming) is a form of nociceptor neuroplasticity, a long-
lasting change in nociceptor function, induced by trauma, inflammation, and stress. Therefore, it
is of great interest to determine if the high incidence of pain in the elderly is related to priming,
and whether it is caused by systemic inflammation, and if the treatments that reverse priming
could provide a basis for the treatment of chronic pain in the elderly. In Aim (1) we propose to
establish that aged rats express nociceptor plasticity (priming), the age at which priming develops,
and if priming is associated with systemic inflammation (measuring the levels of circulating
inflammatory cytokines) in F344xBN elderly rats. In Aim (2) we propose to identify mechanisms
underlying priming in the elderly, determining the role of Type I and Type II priming in age-
associated priming, and in which nociceptor population priming occurs. It is also known that age-
related changes in mitochondria are associated with decline in mitochondrial function and,
recently, mitochondrial dysfunction has been implicated in priming. Therefore, in Aim (2) we will
also test the hypothesis that systemic inflammation and increased reactive oxygen species (ROS)
production by mitochondrial dysfunction, result in priming. We will evaluate, by
immunofluorescence, if ROS activity is greater in dorsal root ganglia (DRG) from aged rats, if
modulating mitochondrial electron chain transport complex and scavenging a mitochondria-
specific superoxide, in vivo, alleviates age-associated priming, and evaluate the oxygen
consumption rate, ex vivo by the seahorse analyzer, to better understand how the main
mitochondrial energy producing pathways are altered in association with age-associated priming,
in DRG neurons. Since there are sex differences in pain syndromes in the elderly, and in priming,
all the proposed experiments will be performed in both sexes, paving the way to more
personalized management of pain in the elderly. The results of the proposed studies may be useful
as a guide for the development of novel therapeutics for the prevention and treatment of chronic
pain in the elderly.

Public health relevance
Project Narrative We propose to test the hypothesis that the high incidence of pain in the elderly is due to hyperalgesic priming, caused by cellular senescence and systemic inflammation. Elucidating the Type of priming, the nociceptor population in which it occurs, the role of mitochondrial dysfunction, and the sex differences in priming could provide valuable information about pain mechanisms in the elderly, leading to a more effective and personalized management of their chronic pain.